Ultra-high Resolution 3D MR Spectroscopic Imaging

? DESCRIPTION (provided by applicant): The non-invasive acquisition of spatial distributions of biochemical information with magnetic resonance spectroscopic imaging (MRSI) promises to enormously enhance our ability to detect and diagnose disease, to monitor the efficacy of therapy, and to increase our understanding of the body's basic physiology. However, clinical and research applications of MRSI have been developing slowly due to several long-standing technical barriers, including long data acquisition time, poor spatial resolution, low signal-to-noise (SNR), and overwhelming nuisance signals (for 1H-MRSI). In order for MRSI to become a routine diagnostic and research tool, accurate, spatially- resolved spectral information must be obtained reproducibly in a time acceptable to patients. Current MRSI methods, after more than three decades of research efforts and progress, still fall short of providing an adequate combination of resolution, speed, and SNR for routine in vivo applications. The primary objective of the proposed project is to develop a new technology for MRSI to achieve an unprecedented combination of resolution, speed, and SNR for 3D ultra-high resolution MRSI of the brain. This objective will be achieved by leveraging the recent breakthroughs in sparse sampling theory and subspace imaging through concentrated research efforts on: a) developing and implementing a novel data acquisition method and pulse sequence for highly accelerated spatiospectral encodings with sparse sampling of (k, t)-space; b) developing and implementing effective methods for removal of nuisance signals (water and lipid signals) and for image reconstruction from highly sparse (k, t)-space 1H-MRSI data; and c) analyzing the resolution and noise properties and reproducibility of the proposed method by theoretical analysis, computer simulations, and experimental studies. The successful completion of the project will have a major impact on the field of MRSI by providing a key technology advance to make high-resolution MRSI practical. It will also open up new exciting opportunities for further MRSI technology development and innovations that will enable a wide range of basic and clinical applications of high-resolution MRSI.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will generate a new technology for magnetic resonance spectroscopic imaging to enable 3D ultra-high resolution metabolic imaging of the brain.